Enrichment Program

Enrichment Program Aims

Aim 1. To create an educational and academic environment to support innovative type II translation research by: (a) Hosting academic and research presentations, panel discussions, and Grand Rounds with diverse faculty to share knowledge and expertise and promote skill-building and collaborations in diabetes translation research; (b) Leveraging opportunities at Atlanta- and regional partner institutions beneficial for building knowledge/skills in diabetes, translation research, appropriate technologies, grant writing, research methods, etc.; (c) Planning networking events to support, foster, and build collaborations between investigators at our partner institutions; and (d) Promoting equity through selection of speakers.

Aim 2. To create a central repository and venue for sharing knowledge, study tools, and materials in diabetes translation research through: (a) State- and region-wide publicly available storage of recorded lectures and panel discussions; and (b) Virtual and (when feasible) in-person networking events to support, foster, and build collaborations between investigators at our partner institutions and other key investigators, physician-scientists, communities, and stakeholders across Georgia and the Southeastern U.S.

Aim 3. To support the expansion of junior and faculty working and thriving in the field of diabetes translation research through the formation of small, mentor-guided, peer working groups for junior and faculty and post-doctoral fellows to provide a supportive environment and build skills in grant writing, manuscript preparation, time management, overcoming challenges, work-life balance, and problem solving.

Aim 4. To evaluate and improve Enrichment programming through member surveys and interviews. The Enrichment Program will work closely with the GCDTR Cores and P&F Program to ensure programming and outreach that meet the needs and preferences of our members and enable communication and dissemination of scientific information across all Center institutions, regional affiliated institutions, faculty, collaborators, and users of all types. As a focal point of the GCDTR, the Program will continue to provide a rich environment of ideas and networks from which cross-disciplinary collaborative projects can be developed."

Public health relevance
Modified Public Health Relevance Section Enter the text here that is the new public health relevance information for your application. Using no more than two or three sentences, describe the relevance of this research to public health. The Georgia Center for Diabetes Translation Research (GCDTR) advances the prevention and management of diabetes by accelerating the real-world application of proven interventions in clinical and community settings. Through interdisciplinary research, community engagement, and data-driven innovation, the Center supports improved health outcomes across populations. Its work delivers sustainable, scalable solutions that inform policy and practice to reduce the burden of diabetes locally and nationally.